Calcium dysregulation and vulnerability of entorhinal cortex neurons in Alzheimer's disease

ABSTRACT The broad, long-term objective of this multi-PI grant application is to understand the role of calcium (Ca2+) dysregulation as the mechanistic driver for synaptic loss between the lateral entorhinal cortex (LEC) and hippocampus (HPC) in evolving Alzheimer’s disease (AD). While dysfunction of LEC-HPC circuit has been implicated in the early stages of AD, the cause of this early, selective vulnerability of LEC neurons and disruption of LEC-HPC connections remain unknown. In our studies we will test the hypothesis that dysregulation of neuronal Ca2+ signaling plays a key role in LEC-HPC circuit dysfunction in early AD. Specifically, in experiments with the APPKI mouse model of AD, we will investigate if normalization of the activity of the Ca2+-dependent phosphatase calcineurin (CaN) rescues defects in LEC?HPC communication in early AD. The peptidyl-prolyl isomerase Pin1 is one of the key targets of CaN in neurons. Elevations in CaN inhibit Pin1, directly leading to synaptic and neuronal loss. In experiments with APPKI mice, we will determine if restoration of Pin1 activity rescues defects in LEC?HPC communication in early AD. We will use a combination of molecular, biochemical, imaging, electrophysiological, behavioral and neuropathological techniques to address these specific aims. If successful, our studies will provide a mechanistic rationale for the use of CaN inhibitors to treat early AD, potentially correcting early dysfunction of the LEC-HPC circuit and slowing AD development.

Public health relevance
PROJECT NARRATIVE The proposed project will have direct and immediate relevance for public health. Alzheimer’s disease (AD) is a major cause of dementia in the elderly and an enormous health problem. This Multi-PI project is focused on understanding the molecular mechanisms that lead to early synaptic dysfunction early in the disease. If successful, our studies will facilitate selection of therapeutic agents that have potential to correct memory dysfunction at early stages of AD.